Core A: Administrative Core

PROJECT SUMMARY/ABSTRACT
The purpose of the Administrative Core is to support the translational research objectives of our SPORE in
Prostate Cancer by serving as the organizational hub, optimizing collaboration among SPORE investigators.
The specific aims of the Administrative Core are (1) provide coordination for all scientific and educational
activities of the SPORE, and (2) provide centralized administrative support of day-to-day activities to all the
components of the SPORE: research projects, cores, and developmental research and career enhancement
programs. The services centralized in the Administrative Core provide the following administrative and
communications infrastructure that serve all components of the SPORE.
* Financial Management: serving as the centralized SPORE budgetary coordinator and financial manager
* Grants Administration: serving as administrative liaison to the National Cancer Institute, ensuring the
timely submission of all required reports and compliance with institutional and federal regulations, as well
as the annual solicitation of new pilot and career projects
* Patient Advocacy: developing initiatives to enhance patient and community engagement and increase
clinical trial enrollment, particularly among patients from minority and underserved populations
* Meetings Coordination: organize the scientific review of ongoing SPORE research projects, cores, and
pilot and career projects
* Communication: foster communication and collaborative research within our SPORE as well as with other
prostate SPOREs, the Prostate Cancer Clinical Trials Consortium, and the wider scientific community
* Editorial Services: providing editorial services for manuscript publication and ensuring compliance with
public access requirements for SPORE-funded science
* Data Management: supporting the maintenance and enhancement of data management systems for
multiple types of research data and ensuring deposition of relevant genomic data in appropriate
repositories
The Administration Core is led by Howard I. Scher, MD, and Yu Chen, MD, PhD, who oversee all SPORE
activities along with SPORE Executive Committee members Charles L. Sawyers, MD, and Michael J. Morris,
MD. Patient advocacy efforts will be led by Susan F. Slovin, MD, PhD. The Administrative Core also includes
personnel trained in financial management, grants administration, medical editing, data management, and
clerical support.